Angiogenesis and Vascular Disease

ABSTRACT Support is requested for a Keystone Symposia conference entitled Angiogenesis and Vascular Disease, organized by Drs. M. Luisa Iruela-Arispe, Timothy T. Hla and Courtney Griffin. The conference will be held in Santa Fe, New Mexico from May 8-12, 2017. Angiogenesis is critical to both the growth and repair of tissues as well as for the progression of several pathologies. Progress in our molecular understanding of vascular growth has facilitated the development of therapies that have been successfully applied in diseases such as retinopathy and cancer. Notwithstanding these advancements, much remains to be harnessed from the basic molecular mechanisms that control vascular growth. This conference will bring together leaders of research from basic science, translational science, biotechnology and pharmaceutical areas, to discuss progress in clinical and translational research areas. The goal of the conference is to highlight new discoveries, technological advances and therapeutic possibilities. Both established and up-and-coming investigators will have ample opportunities to interact informally and share views with junior investigators and trainees in a collegial and relaxed atmosphere. By promoting cross-disciplinary interactions, the conference will enhance vascular biology research and applications to clinical medicine. Opportunities for interdisciplinary interactions will be further enhanced by the concurrent conference on Mitochondria, Metabolism and Heart, which will share a keynote address and plenary session with this conference. Relevance to NHLBI: The central theme of the conference focuses on mechanisms that regulate vascular growth and their deregulation during disease. Research that focuses in addressing vascular health is one of the main missions of NHLBI, therefore we consider that the institute would not only support but embrace discussions related to recent advancements in this area.

Public health relevance
PROJECT NARRATIVE Vascular biology has evolved over the past decade as a major cross-disciplinary field of study with impact on several major human diseases that expand the more traditional vessel wall pathologies, such as atherosclerosis and hypertension. Today, vascular biology also contributes to our understanding of cancer, neurological disorders, diabetes, stroke, hematological disorders and various immunological diseases, as well as the development of many new therapies and preventive strategies with broad impact. The Keystone Symposia conference on Angiogenesis and Vascular Disease has been designed to provide a view of the most recent breakthrough advances at the intersection of angiogenesis with Metabolism and to consider their impact and significance in the context of the established dogmas and current hypothesis.